DEvelopment of cancer predictive models informed by geneTic and EnviRonMental exposures and their interactions to Improve caNcer screening and prEvention strategies (DETERMINE)

Given the uniqueness of the VA population, any serious attempt to produce precision screening or treatment
for cancer risk must account for and understand the effects of military and lifetime environmental
exposures. However, uncertainty exists around the specifics of genetic susceptibility to exposures.
Furthermore, patterns of mutations in cancer left by military exposures have not been characterized. The
overarching goal of this proposal is to improve clinical screening and treatment of Veterans by accounting for
both exposures and genetics. Cancers chosen for analysis in this proposal are prostate, lung, and bladder
cancer. Exposures chosen for analysis in this proposal are exposure to Agent Orange, contaminated
groundwater at Camp Lejeune, cigarette smoke, ambient air pollution, and lifetime radon. We propose to
identify genetic loci which more strongly predispose individuals to the carcinogenic effects of these exposures,
and to build precision risk prediction models capable of more accurately predicting cancer risk in a VA
population. We will additionally characterize mutational changes in the cancer genome that are attributable to
specific prior exposures and use the patterns of these mutational changes—and their relationship to germline
genetics—to further identify key genetic loci for exposure susceptibility and to improve risk prediction. This
proposal is unprecedent in the scale at which it combines exposure, germline, and somatic genotyping data.
We additionally propose entirely novel approach to identify mutational signatures that represent prior
exposures. This proposal will improve Veteran health care through 1) creation of personalized risk scores
for targeted cancer screening 2) unlocking the ability to identify subtypes and signatures of cancer specific
to exposures 3) constructing an exposure derived signature map in which clinicians can search for driver
mutations in individual patients to drive their individual therapeutic strategies.

Public health relevance
In this project we propose to uncover the genetic and environmental exposure factors that are associated with development of cancers. We propose to integrate data from the VA’s Million Veteran Program (MVP), National Precision Oncology Program (NPOP) and Military Exposure Research Program (MERP) to derive comprehensive polygenic + environmental risk scores to estimate an individual Veteran’s risk of developing cancer. This represents the largest and most comprehensive investigation into genetic effects of known military exposures on cancer development. This individual risk information can in turn be potentially used to identify population with the most need for screening thereby enabling early detection of the disease in Veterans.